Admin Core

Summary/Abstract
The Administrative Core is critical for the overall success of the Center of Excellence for Malaria Research
(ICEMR) Program for Resistance, Immunology, and Surveillance of Malaria in Uganda (PRISM) by supporting
linkages between the projects and cores under one umbrella. This Core will provide scientific leadership,
organize meetings and transportation, provide administrative, fiscal and human resource services, and
facilitate communications both for internal program key personnel and external advisors. The Administrative
Core will coordinate scientific workshops including the Scientific Advisory Group, hosting research
dissemination meetings with local policy makers and key stakeholders, and one ICEMR workshop as required.
The Administrative Core will have both a US and Uganda component to meet the needs and services for both
cores and three research projects in this program. In the US, UCSF will act as the recipient organization,
overseeing the fiscal management for the multiple institutions' subcontract awards, oversight of the regulatory
compliance for all collaborating institutions, and ensure appropriate communication between the collaborating
institutions, the sponsor, and the regulatory agencies. In Uganda, where a majority of the work will be
performed, program administration will be managed by the Infectious Diseases Research Collaboration (IDRC)
and will oversee the progress and operations of the Center's endemic country operations including fiscal,
human, and resource management, organize and facilitate the scientific meetings and communications, and
support local research activities. The administrative staff in the U.S. and Uganda has a track record of working
together to administer complex projects, including 13 years on the PRISM program to date, and to adapting to
the ever changing fiscal and regulatory requirements of international research. Key accomplishments of this
PRISM Administrative Core since 2010 include: administering subcontracts to multiple US and international
collaborating institutions; hired and maintained over 250 staff in Uganda involving more than 70 field sites;
maintaining Material Transfer Agreements for more than 20 specimen shipments; IRB submissions for
approximately 10 human subjects projects and 2 training projects; organized monthly PRISM all-project calls,
at least annual PRISM team retreats in Kampala, annual in-person or virtual SAG meetings, 4 Ministry of
Health and other key stakeholder research dissemination meetings, organizing two ICEMR Networking
Conference in Uganda (August 2016 and January 2024); and supported training projects embedded within
PRISM. The specific objectives of the Administrative Core will be: 1) to provide scientific leadership to ensure
that each project achieves its scientific goals in a timely and efficient manner, 2) to provide organizational
management of all aspects of the program, including fiscal, human and resource management, and regulatory
oversight, 3) to support internal linkages between the projects and cores and external linkages with the funding
agency and scientific advisors, including organization of one all ICEMR conference.